Statistical & Data Management Core

The overall goal of the Statistics and Data Management Core (Core B) is to continue providing the computational and analytic resources to support the overall Program Project Grant (PPG) mission of elucidating the molecular neurobiology of mild cognitive impairment (MCI). More specifically, Core B will assist with study design, tissue selection, data management, statistical analysis, and results interpretation to ensure the success of each PPG investigator. Specifically, the core will provide data management linking existing clinical and neuropathological data from the Rush Religious Orders Study (RROS) housed in the Rush Alzheimer's Disease Core Center (RADCC) with the cellular and molecular findings from the four proposed Program Project Grant (PPG) subprojects. To accomplish this. Core B will: Extract and retrieve relevant data from the RROS clinical and neuropathological databases; expand, document, and maintain a library of PPG laboratory data and merge RROS data with PPG laboratory data for statistical analysis. In addition, the Core B will identify eligible cases based upon inclusion/exclusion criteria specified by the PPG while maintaining blinding of investigators to clinical and pathological diagnoses. Finally, provide statistical support for study design, prepare all analytic data sets across projects, perform statistical analyses as needed, and assure statistical accuracy in interpretation and presentation of results. The statistical research team is experienced in the conduct of neuropathological studies involving human tissue samples and has been working with the PPG for over 12 years.

Public health relevance
A centralized database with uniform measurements assures quality data is being collected in this PPG grant. Reliance on experienced statistical advisors for addressing study design and data analysis assures the questions addressed by each subproject are being approached in an optimal and sound manner.